DEVELOPMENT OF NANOFLOW METHODOLOGY W/ ONLINE ELECTROSPRAY DETECTION

LCMS at high sensitivity (femtomole range) using nanoscale columns and the focal plan array detector. Positive and negative selection moiety monitoring via cone voltage induced fragmentation for location of posttranslational modifications. (Additional effort and instrument time reported under Collaborative projects and other Technical Research and Development projects.)